Rescue and repair of stalled ribosome damaged by ribosome-specific ribotoxins

Project Summary/Abstract
Colicin E3 was the first ribotoxin to be characterized 50 years ago. It makes a single but precise cut of
16S rRNA in the decoding center of bacterial ribosome, resulting in stalled ribosome and eventual cell
death. Over the last half of a century, it is unclear whether there exists a biological system that is able to
reverse the ribosomal damage by colicin E3 to allow cell to survive. Employing approaches of
bioinformatics, biochemistry, structural biology, and microbiology, we have uncovered a bacterial two-
component system, RtcB and PrfH, as the antidote of colicin E3. Specifically, bacterial PrfH recognizes the
damaged and stalled ribosome and performs ribosomal rescue. This is followed by RtcB repairing the
damaged 30S ribosomal subunit. The sequential events described above are supported by abundant
preliminary data from both our in vitro and in vivo studies. In this application, we plan to significantly expand
our preliminary studies to systematically characterize the rescue and repair of bacterial ribosome with
specific damage in the decoding center with the following three main aims: (1) We will provide insight into
bacterial PrfH recognizing and rescuing the damaged and stalled 70S ribosome in vitro; (2) We will
biochemically and structurally characterize bacterial RtcB in vitro, with the emphasis of PrfH-coupled RtcB
repairing the damaged 30S ribosomal subunit; and (3) We will elucidate in vivo biological functions of RtcB-
PrfH using an in vivo attenuated RNA damage system we have developed.

Public health relevance
Project Narrative Some bacteria release ribotoxins that target protein translation system for cell killing, and others have acquired RNA repair systems to neutralize the toxic effect of ribotoxins for survival. The RNA repair systems appear to be concentrated on pathogenic bacteria. Therefore, blocking RNA repair in these bacteria with small-molecule inhibitors may lead to their demise, resulting in potential prevention and treatment of human diseases.